The Minnesota TMD IMPACT Collaborative: Integrating Basic/Clinical Research Efforts and Training to Improve Clinical Care

SUMMARY
Temporomandibular disorders (TMD) is an umbrella term that includes dysfunction and pain involving
the temporomandibular joint (TMJ) as well as the masticatory muscles. TMD is the second most common
chronic musculoskeletal condition after chronic low back pain, affecting approximately 10 to 15% for adults and
4% to 7% for adolescents. The etiology of TMD is considered multifactorial, and several risk factors appear to
predispose, precipitate, or prolong pain during TMD, including biological factors (e.g., sex hormones),
endogenous opioid function, differences in anatomical genotypes, trauma, oral parafunctions, and
psychosocial factors (e.g., stress exposure, pain coping, stress, catastrophizing). The mechanisms that initiate
and promote pain during TMD have not been determined. TMD pain can severely affect the individual’s daily
activities, causing psychosocial dysfunction and worsening quality of life, thus it is important to develop means
for early detection and provide effective treatments for those afflicted. This proposal aims to establish a
collaborative group with an overall goal to improve the diagnosis and treatment of TMD patients with pain. To
accomplish this goal, a collaborative team will work to create a multidisciplinary program composed of clinical
and basic researchers, dentists, physicians, and patient advocates focused on the following four pillars:
clinical care, research, education, and consumer engagement. Several of the focus areas for the Minnesota
Collaborative align with the NIH initiative, TMD Collaborative for Improving Patient-Centered Translational
Research (TMD IMPACT). In order to position this collaborative to achieve these four pillars, a patient registry
will be established to collect and make data ready for analysis for clinical and basic research to improve the
diagnosis and treatment of pain in TMD patients. Four specific aims were designed to support the collaborative
effort in the initial phase: an infrastructure for patient enrollment and pilot data collection will be established
(Aim 1); a comprehensive patient database for the adaptive trial on TMD will be developed and implemented
(Aim 2); a biobank and biomarker analysis pipeline will be established (Aim 3); and a plan to combine research
training with specialty training in TMD will be developed (Aim 4). The overall objective of this proposal is to
establish and nurture a collaborative of principal investigators that includes clinicians and basic researchers
with the common goal to improve the diagnosis and treatment of TMD pain patients by the means of a patient
registry which will collect data and make it ready for analysis for clinical, translational, and basic research.

Public health relevance
PROJECT NARRATIVE Temporomandibular joint disorders (TMD) can present with pain in the oral facial region for which there is currently limited effective treatments. We propose to establish a Collaborative that will include clinical research, basic research, and educational priorities to improve the diagnosis and treatment of patients with pain during TMD. The Collaborative will be centered around a patient registry to establish a database from which clinical and basic research will accelerate translation to evidence-based treatments and personalized clinical care for patient with pain during TMD.